Aberrant N-glycosylation in Crohn's disease: Opportunity for precision medicine

ABSTRACT
Crohn’s disease (CD), and the related condition of ulcerative colitis, are chronic inflammatory bowel diseases
(IBD) that impact 3.1 million Americans. While anti-cytokine therapies have revolutionized care, clinical remission
is only achieved in 40% of patients with CD – a therapeutic ceiling that has not changed in 20 years. These data
underscore the need for new treatment strategies. We are focused on understanding the role of defective
N-glycosylation in CD as an innovative strategy to study pathophysiology and develop new therapeutics.
Depending on the ancestral background, 7-25% of patients with CD carry a pathogenic, missense mutation in
the manganese (Mn) transporter ZIP8 (ZIP8 A391T). ZIP8 regulates systemic Mn homeostasis via enteric and
hepatobiliary Mn absorption. ZIP8 391-Thr causes a relative Mn insufficiency that impairs Mn-dependent N-
glycosylation. Our central hypothesis is that CD is exacerbated by aberrant N-glycosylation in patients with
ZIP8 391-Thr and that this defect can be targeted by specific, safe therapy. Supporting this hypothesis, blood
Mn levels are 15% lower and complex, branched N-glycans are decreased in plasma in ZIP8 391-Thr carriers.
Further, we uncovered an ileal microbiota signature that implicated altered bile acid homeostasis in ZIP8 391-
Thr carriers. We generated a knock-in (KI) mouse model (Zip8 393T-KI) that recapitulates findings of these
human studies. Promising human trials have shown that defects in N-glycan branching can be safely restored
by raising levels of the rate-limiting metabolite UDP-N-acetylglucosamine (GlcNAc) via supplementation, sparing
risks related to direct Mn supplementation. Our preliminary data in Zip8 393T-KI mice have demonstrated that
GlcNAc supplementation restores N-glycan branching deficits in the gut and rescues defects in bile acid
homeostasis, intestinal permeability, and colitis susceptibility. Thus, our objective is to use the Zip8 393T-KI mice
to study the molecular impact of decreased N-glycan branching in the ileum and develop aberrant N-
glycosylation as a therapeutic target in CD. In Aim 1, we will elucidate how ZIP8 391-Thr impacts systemic Mn
homeostasis to impair Mn-dependent processes. We will use study of bile acid homeostasis, determined by the
activity of the key ileal glycoprotein, apical sodium-dependent bile acid transporter (Asbt), as a model to
determine the impact of decreased N-glycan branching. These mechanistic studies will be complemented by the
unbiased approach of glycoproteomics to expand our understanding of the proteins and pathways perturbed by
ZIP8 391-Thr and decreased N-glycan branching with studies in Zip8 393T-KI mice and ileal biopies from healthy
individuals and patients with active CD. In Aim 2, we will prospectively “glyco-phenotype” patients with CD to
inform on the spectrum of N-glycan branching defects in patients with CD, and we will test the efficacy of oral
GlcNAc supplementation in patients with CD and ZIP8 391-Thr in a randomized, placebo-controlled, cross-over
study. Together, these studies will assess the impact of aberrant N-glycosylation in CD and accelerate progress
towards targeted, genotype-specific, glycosylation-directed therapies.

Public health relevance
PROJECT NARRATIVE One in 10 patients with Crohn's disease carry a mutation in the manganese transporter ZIP8 that causes a problem in Mn-dependent processes, including glycosylation – a process that helps to decorate proteins with sugars to help direct them to where they need to go and what other protein interactions they will have. This application will seek to learn how the ZIP8-related problem with glycosylation affects the ileum and if patients with ZIP8 391-Thr will benefit from specific, targeted therapy to treat the glycosylation problem.